Impact of routine eye care coverage on access to eye care and fall-related outcomes among low-income Medicare enrollees

PROJECT SUMMARY/ABSTRACT
Vision problems are prevalent among older adults, with about 92% of Medicare enrollees ages 65 and older
using vision correction, and 39% of Medicare enrollees who use vision correction reporting trouble seeing even
with eyeglasses. Visual impairment is associated with increased morbidity and mortality, including an
increased risk of falls and hip fractures. While most fee-for-service Medicare enrollees do not have coverage
for routine eye exams and glasses, some low-income Medicare enrollees have comprehensive vision coverage
if they qualify for full Medicaid benefits (“dual eligibles”) and reside in a state with a Medicaid program that
covers vision services. The objective of this proposal is to use quasi-experimental methods to estimate the
effect of Medicaid coverage of routine eye exams and glasses on eye care access and fall-related outcomes
among dual eligibles during 2000-2019. The central hypothesis is that coverage of vision services will increase
eye care visits and reduce the risk of falling by improving vision. The central hypothesis will be tested by
pursuing three specific aims: 1) to examine the effects of Medicaid vision benefits on measures of access to
eye care and vision including eye care visits, unmet needs for glasses, out-of-pocket spending on routine eye
care, self-reported trouble seeing, functional limitations due to vision, and Medicare claims-based measures of
past-year treatment for glaucoma, cataracts, and age-related macular degeneration; 2) to examine the effects
of Medicaid vision benefits on fall-related outcomes including self-reported falls, fall-related injuries, and activity
limitations due to fear of falling and administrative measures of treatment for falls; and 3) to evaluate the
effects of Medicaid vision benefits by sex, race and ethnicity, diabetes diagnosis, and by Alzheimer’s disease,
related dementias, and memory loss. The research proposed in this application is innovative because it will
use several complementary data sources including linked survey and administrative claims data to examine
measures of eye care access and fall-related outcomes, compile a comprehensive database of Medicaid vision
benefit policies over a more than 20 year period to be shared with researchers, combine a quasi-experimental
approach with a 9 year panel of individual longitudinal data, and apply newly developed methods to address
variation in the timing of state policy changes. The proposed research is significant because the number of
adults ages 65 and older is projected to more than double over the next 40 years. Correspondingly, the
prevalence of vision problems and injurious falls is likely to increase significantly over this period. The
proposed aims will produce the first estimates of the effects of Medicaid vision benefits on eye care access and
fall-related outcomes among dual eligibles. The public health impact of this research will be to provide critical,
timely, and policy relevant evidence on the effects of increased access to vision care among older adults and
the role of public health insurance.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will inform policy discussions around state and federal proposals to cover vision services by providing rigorous estimates of the effects of routine eye care coverage on access to vision care and fall-related outcomes among dual eligibles. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to enhancing health and reducing illness and disability. This application is also relevant to the part of NEI’s mission that pertains to protecting and prolonging vision, and to the part of NIA’s mission that pertains to improving the health and well-being of older adults.